Project 3: Improving therapeutic approaches for breast cancer brain metastases

Project Summary
Breast cancer brain metastases (BCBM) affect up to half of patients with advanced HER2+ breast cancer and 10-15% of
patients with advanced ER+/HER2- breast cancer. Standard of care includes surgery and/or radiotherapy; however, these
approaches can be associated with substantial toxicities, do not address systemic disease, and leave patients at risk for
future central nervous system progression (CNS) and death. Despite their clinical impact, existing preclinical models of
BCBM have been limited, and the factors which influence BCBM growth are not well elucidated. To date, no systemic
therapy has gained regulatory approval for the treatment of BCBM—hence this represents an area of major, persistent, and
unmet medical need. Preclinical investigations, including our own, have suggested a role for at least two key pathways—
PI3K/PTEN/mTOR and cyclin D1/CDK4—in the growth and maintenance of BCBM. The overarching goals of this project
are to elucidate the roles of the PI3K/PTEN/mTOR pathway and the Cyclin D1/CDK4 pathway in the growth and
development of BCBM, to dissect the basis of site-specific response/resistance to inhibitors of these pathways, to test the
clinical utility of targeting the pathways in patients with BCBM, and to identify ways to predict and overcome therapeutic
resistance, with the long-term goal of identifying more effective treatment and prevention strategies. To accomplish our
aims, we have assembled a multidisciplinary team enabling close bi-directional collaboration between the laboratory and
clinic. We will leverage our unique collection of patient-derived xenograft (PDX) models generated from human BCBM
specimens, and genetically-engineered mouse models (GEMMs), married with state-of-the art molecular pathology
techniques. In Aim 1, we will 1) test whether PTEN loss promotes the growth and maintenance of BCBMs, and evaluate
the effects of genetic or pharmacologic restoration of PTEN expression; 2) evaluate brain-penetrant PI3K/mTOR inhibitors
in preclinical models of BCBM and uncover potential mechanisms of site-specific resistance; and 3) test the efficacy of
combined PI3K/mTOR blockade in patients with HER2+ BCBM. In Aim 2, we will 1) evaluate the efficacy of CDK4/6
inhibition, alone and in rational combinations, 2) evaluate the efficacy and immuno-modulatory effects of CDK4/6 inhibitors,
alone and in combination with immune checkpoint blockade and in varying genetic backgrounds, and 3) explore the clinical
efficacy of combined HER2 and CDK4/6 inhibition in patients with HER2+ BCBM. Together, these studies will further our
understanding of the pathophysiology of BCBM, strengthen our ability to overcome therapeutic resistance, and improve
outcomes for patients with this disease.

Public health relevance
Project Narrative Brain metastases remain an important clinical challenge in breast cancer, for which there are currently no FDA-approved systemic or targeted therapies. Recent data implicate the PI3K/PTEN/mTOR and cyclin D1/CDK4 pathways in the growth and maintenance of brain metastases and provide potential targets for therapeutic intervention. Our proposal aims to further our understanding of the unique vulnerabilities of breast cancer brain metastases and to move forward new therapeutic approaches in order to improve outcomes for this devastating site of disease involvement.